Social networks, neighborhood food environments, diet, and obesity risk in low-income adults

PROJECT SUMMARY/ABSTRACT
Obesity is a public health epidemic in the United States and contributes to many other adverse cardiometabolic
outcomes, such as heart disease. Unhealthy diet is a major risk factor in the etiology of obesity, and low-income
individuals and women with young children experience disproportionate rates of both inadequate nutrition and
excess weight. Interventions to improve dietary patterns have had mixed success, likely because they have
targeted the individual, and largely ignored the complex ecological systems that influence eating. Precision
nutrition science initiatives are encouraging more understanding of the complex systems that influence diet.
Two systems that may be especially impactful for low-income individuals are social networks and neighborhood
food environments, as these individuals tend to be embedded in social networks with less resources and support,
and they are more likely to live in neighborhoods with reduced access to healthy food. Many features of these
two systems have been linked with unhealthy dietary patterns, such as living in a food desert and having a social
network that is mostly overweight. However, previous social network studies have not examined other key
features and have had methodological limitations such as lack of population-level data, and sparse information
of few network members. Social networks and neighborhood food environments have also been studied in
isolation, meaning the synergistic impact of these systems on the diets of low-income populations is not
understood.
The goal of this study is to examine, simultaneously, the main and interaction effects of (1) living in a food desert
and (2) personal social network characteristics on the dietary patterns and body mass index (BMI) of low-income
adults and mothers. This project will leverage data from two unique datasets that each have notable strengths:
(1) The Understanding America Study, with longitudinal data from 550 low-income individuals who are
representative of Los Angeles (LA) County, CA, allowing for the identification of population-level effects and (2)
The NICHD-funded Healthy Habits clinical trial, with both qualitative and quantitative longitudinal data from 70
low-income mothers in Antelope Valley, LA County, CA, allowing for an in-depth mixed methods exploration.
The findings from this study will give a fully-formed understanding of the independent and synergistic impacts of
social networks and neighborhood food environments on dietary patterns and BMI, and contribute to
interventions that are tailored to multiple levels of influence. The award of this fellowship will allow Ms. Miller to
pursue advanced training opportunities in Social Network Analysis, Geographic Information Science, and
longitudinal and population-level data analysis, in pursuit of her goal of becoming an independent academic
research scientist.

Public health relevance
PROJECT NARRATIVE Although poor dietary patterns are a putative risk factor for the development of obesity and related diseases, the success of dietary interventions is limited, as previous studies have not fully examined the socio-environmental systems which influence eating in groups who have increased risk for excess weight, such as low-income adults and mothers. Two systems that may be especially impactful for these individuals are social networks and neighborhood food environments, but previous studies have been limited by a lack of population-level data and sparse social network information, and these influences have been studied in isolation rather than synergistically. This project addresses these gaps in the literature by leveraging a population-level dataset and a rich, mixed methods dataset to examine the main and interaction effects of neighborhood food environments and social networks on dietary patterns and body mass index in low-income adults and mothers, with the goal of informing future multilevel intervention programs.